Dual Role of HSP70 in Diabetes-Induced Vascular Dysfunction

Dual role of HSP70 in diabetes-induced vascular dysfunction
R15 – Applicant Kenia Nunes
Project Summary/Abstract
Vascular damage, a significant health problem, is linked to hyperglycemia, a key component of
both types of diabetes. The rationale for this study is that increased glucose levels chronologically
associate with higher levels of circulating Heat-shock protein 70 (HSP70), an intriguing molecular
chaperone that co-exists in different cell compartments and exerts antagonistic actions. There is
a well-known crosstalk between HSP70 and Ca2+, but not in smooth muscle. Only recently, my
lab showed that a functional iHSP70 is required for adequate vascular reactivity under
physiological conditions, as it impacts Ca2+ handling mechanisms. In diabetes, there is an
increase in the levels of eHSP70, which is associated with oxidative stress and low-grade
inflammation. Thus, it is reasonable to argue that HSP70 could determine the outcome of vascular
damage in this disease. Still, it is unknown if iHSP70 affects vascular Ca2+ signaling under
hyperglycemic conditions and if eHSP70 contributes to vascular functional and structural
alterations in diabetes. The central hypothesis of this project, formulated based on the literature
and my robust preliminary data, is that HSP70 plays a dual role in diabetes-induced vascular
dysfunction. This study is innovative because it will independently investigate the interplay
between iHSP70 and Ca2+ handling mechanisms leading to functional and structural changes
under hyperglycemia and by selectively targeting eHSP70 in a murine model of type 2 diabetes
to prevent these changes. I will combine a set of well-established in vitro, ex vivo, and in vivo
approaches, by using state-of-art techniques such as atomic force microcopy and
ultrasonography (Pulse Wave Velocity) to allow observations at macro, micro and nano scale.
Also, sex plays a crucial role in determining the tissue rate of production of HSP70; therefore, we
will use male and female animals. The experiments outlined in this study will address each specific
aim efficiently by utilizing the strengths of my laboratory. Moreover, network between biology and
engineering will be stablished by collaboration with a senior professor in Biomedical Engineering.
The PI has extensive experience in the field and will closely supervise the students. The outcome
of this research has an enormous potential to uncover target mechanisms to manage diabetic
vasculopathies while creating a multidisciplinary environment offering extensive research training
to undergraduate students. Our findings will have a broader impact by opening new research
avenues for other diseased states associated with vascular structural and functional changes.

Public health relevance
Dual Role of HSP70 in diabetes-induced vascular dysfunction PI: Kenia Nunes – R15 Project Narrative Hyperglycemia positively correlates with the severity of the vascular damage and the extracellular levels of the molecular chaperone Heat-shock protein 70 (eHSP70). My lab recently demonstrated a crosstalk between intracellular (i)HSP70 and vascular Ca2+ handling mechanisms under physiological conditions. Here, I will investigate the dual role of HSP70 in the vasculature at macro, micro, and nano scale, by characterizing the interplay between iHSP70 and Ca2+ handling mechanisms under hyperglycemia (T2D) and by selectively targeting eHSP70 in diabetes to prevent vascular functional and structural changes.